NEUROPEPTIDES--MOLECULAR MECHANISM OF ACTION

Deltorphins (DEL A,B, or C), highly selective opioid heptapetides, were used as molecular and chemical probes for brain opioid receptors. Receptor binding analyses and pharmacological assays using peripheral tissues enabled a delineation of specific molecular properties for agonist/antangonist interactions. Key molecular features of DEL were based on the study of over 180 synthetic analogues: (1) D-Try1,an N-extended TRY1 or a bridged [TRY1-Asp4] in DEL C are unacceptable for binding. (2) A residue with a hydrophobic side-chain is required at position 5, although binding is affected by the sequence in the C-terminal tetrapeptide; inversion of sequence brought about a reversal in selectivity (- ). (3) Substitution by halogens, amino or nitro groups at the para-position of Phe3 modified brain receptor selectivity and bioactivity; whereas [p-BrPhe3] exhibited twice receptor selectivity as DEL C, [p-ClPhe3] and [p-BrPhe3] were nearly 4- and 2-fold higher than DEL C by bioassay (MVD), however, the only correlation between bioactive potency and receptor binding occured with recptors. (4) Modification of the electronic, hydrophobic and conformational properties of Phe3 in DEL C occurred through use of 5 and 6 membered rings and bicyclic structures. In general, these substitutions were deleterious for affinity and selectivity, however, Aic3 and Atc(R,S)3 enhanced affinity; the latter increased selectivity as well. (5) [D-Asp4]-, [Pro4]- or [Abu4]DEL C slighty affected affinities: the former two analogues defined a two-site binding model, while DEL C and [Abu4] DEL C were one-site models. [NaMe Phe 3]- and [Atc(S)3] DEL C revealed that the mimal energy conformer appeared to predict experimentally derived affinities. Futhermore, molecular dynamics calculations implied that the other low energy configurations could describe their conformation during receptor interactions; pseudo-cyclization involving the residues at positions 3 and 4 or replacement by the bicyclic ring structure Atc3 may represent the most desirable solution conformer.